FOOD CHALLENGE WITH COW'S MILK PROTEIN HYDROLYSATE IN ALLERGIC CHILDREN

The purpose of this study is to evaluate which of several cow's milk hydrolyzate formulas may be ingested without difficulty by milk-allergic children.